Sacral neuromodulation for the management of chronic pelvic pain

ABSTRACT
Pelvic pain syndromes are one of the most prevalent and challenging conditions for clinicians today. They have
a higher incidence in women than men and are estimated to affect 6.4 – 25.4% of adult women worldwide.
Chronic pelvic pain (CPP) is defined as nonmalignant persistent pain perceived in structures or organs of the
pelvis for at least 6 months and can have a wide variety of etiologies. CPP has a debilitating effect on quality
of life, equivalent to those on dialysis, and is associated with psychological comorbidity including depression,
anxiety, and sleep disorders. Identifying the origin of the pelvic pain is typically the first step when choosing a
treatment strategy. However, identifying the etiology can be challenging in part because pain associated with
CPP is thought to become centralized over time and the dysfunction of one organ system often resulting in
pathologies in other organs.
Given the complex co-morbid conditions that define the phenotype of most patients with CPP, any treatment
that may potentially improve several downstream pelvic organs and/or symptoms is desirable. As such, we
propose to use sacral neuromodulation (SNM) as a treatment for CPP. SNM is a safe, effective, and minimally
invasive procedure used to treat urinary and fecal incontinence, frequency, urgency, and urinary retention.
Numerous retrospective studies have demonstrated a reduction in pelvic pain as a secondary outcome
measure with SNM. However, to date, no prospective placebo-controlled trial has been performed to assess
the effectiveness of SNM for pelvic pain specifically, in part because SNM is currently not an FDA approved
treatment for CPP. Thus, we hypothesize that sacral neuromodulation is effective at reducing pain in
patients suffering from chronic pelvic pain syndrome. We further hypothesize that single stage SNM
implantation is more cost-effective and provides higher benefit to pelvic pain patients than the
standard-of-care 2-stage approach.
Our hypothesis will be tested through two specific aims: 1. Assess effectiveness of SNM in treating chronic
pelvic pain syndrome in women; 2. Evaluate cost-effectiveness of single stage versus standard-of-care
2-stage SNM. Beaumont Urology is internationally recognized for its expertise in neuromodulation and a large
number of women with CPP seek care at our Women’s Urology Center annually. Thus, our team is well-suited
to successfully complete these aims.
The outcomes of this study will have a far-reaching impact as it has the potential to significantly improve care
for CPP and simultaneously address many unknowns in the field of neuromodulation, such as determine the
placebo and carry-over effects. As such, study falls within the mission of this RFA to foster new and improved
treatment and pain management strategies for patients and to address specific NIDDK disorders of key
importance, namely Urologic Chronic Pelvic Pain Syndrome.

Public health relevance
NARRATIVE Chronic pelvic pain is a debilitating condition affecting up to 1 in 4 women worldwide that is very challenging to treat. This clinical study will evaluate sacral neuromodulation as a treatment strategy for chronic pelvic pain, and determine placebo effect, carry-over effect and treatment durability. In addition, we will assess cost- effectiveness of performing single stage sacral neuromodulation implant versus the standard of care two-stage approach.